Exposure Assessment, Biomarkers, and Environmental Sensing Facility Core

ABSTRACT
The Exposure Assessment, Biomarkers and Environmental Sensing Facility Core (EABES-FC) provides EDGE
investigators with access to state-of-the-art analytical methods, instrumentation and exposure science
expertise, to stimulate their translational and population-based environmental health science research through
inclusion of high quality exposure assessment. The specific focus for development efforts during the following
5-years include (i) Data automation and visualization tools for sensor networks and mobile monitoring data, (ii)
Personal & networked volatile organic compound (VOC) sensors integrated with existing low-cost, GPS-
enabled particle sensors, and (iii) sensor fusion to merge measurements from personal and community
monitors with Geographical Information Systems (GIS) data to improve the accuracy of exposure
assessments. The primary goal of the EABES Core is to provide Center investigators with access to state-of-
the-art exposure assessment tools and approaches.